Cell-cell signaling in archaea: How Haloferax volcanii talk to each other

ABSTRACT
Understanding of the complex network of microbial interactions in the microbiome is integral to human health.
While most microbiome studies have focused on bacterial communities, recent metagenomic analyses report
that archaea comprise a significant percentage of the microbes living in and on our bodies. Yet, little is known
about the impacts of archaea and archaeal signaling in the human microbiome. In this proposal, I aim to study
cell signaling in the model archaeon Haloferax volcanii. In culture, H. volcanii cells at early-log phase are rod-
shaped, which then transition to pleomorphic disks in mid- to late-log phase. Cells stab-inoculated into soft agar
plates can form swimming motility halos, with motile rod-shaped cells at the edge and sessile disk-shaped cells
at the center. Applying cell-free conditioned media (CM) from a late-log culture to a fresh H. volcanii culture
results in exclusively disk-shaped cells at early-log phase. Moreover, when CM is incorporated into soft agar
plates, wildtype H. volcanii does not form a motility halo and instead grows as a nonmotile colony at the site of
stab-inoculation. These results suggest that a secreted signaling molecule in the CM mediates the shape change
and inhibits motility. I have coined the term Disk Forming Signal (DFS) to describe this signaling molecule.
Additionally, mutant strains lacking the protein CirA seem to bypass DFS, remaining as rods throughout growth
in culture and forming motility halos in soft agar supplemented with CM. Interestingly, several mutant strains that
have a disrupted cirA also harbor point mutations in arlI and arlJ, two biosynthesis genes of the archaella, the
archaeal flagella analog. Since cirA is in the same genomic region as arlI and arlJ, a potential link could exist
between CirA and the archaella in motility regulation in response to DFS signaling. In the proposed study, I
aim to discover components of a novel H. volcanii signaling mechanism. I will identify the structure of
DFS via analytical chemistry techniques and investigate the genes involved in DFS biosynthesis by
screening an H. volcanii transposon library. Additionally, I will characterize the role of CirA in the DFS
signal transduction pathway via quantitative proteomics and protein-protein interaction studies between
CirA, ArlI, and ArlJ. Discovering the identity of a signaling molecule produced by H. volcanii, along with defining
the proteins involved in its synthesis, recognition, and response will broaden our understanding of microbial
communities in the healthy human microbiome, begin to unravel the intricacies of signaling among all three
domains of life, and lead to applications of archaeal physiology in medicine and industry.

Public health relevance
PROJECT NARRATIVE An understanding of the complex microbial signaling networks in the human microbiome has led to many insights in health and disease, and yet, little is known about the impacts of archaea or archaeal signaling in and on our bodies. My study will elucidate a novel signaling pathway in the model archaeon Haloferax volcanii. Discoveries in cell-signaling in archaea will begin to unravel the intricacies of signaling among all three domains of life, lead to applications in antibacterial medicine, and reveal a more cohesive understanding of the healthy human microbiome.